NEW ORGANOSILICON MAXILLOFACIAL PROSTHETIC MATERIALS

This research proposes to develop an improved maxillofacial prosthetic material based on a new organosilicon polymer and monomer. The siloxane polymer possesses reactive end groups and will undergo thermal- crosslinking with a siloxane monomer which possesses similar end groups. The indentation hardness, tensile strength, percent elongation, the elongation at break, and tear strength of the material will be determined and compared with those of commercial silicone maxillofacial prosthetic material. The new materials are expected to have strong tear strength, good bonding to the adhesive, good miscibility with the pigments and colorants, and require processing temperature below 100C.